Protein ubiquitination and deubiquitination in neurological disorders

Abstract
Protein ubiquitination is a posttranslational modification that is essential for nervous system function. UB requires
the utilization of a series of enzymes called E1, E2, and E3 that enable the covalent addition of ubiquitin (UB) to
to its cellular targets. Protein ubiquitination is also a highly reversible process which is handled by enzymes
called deubiquitinases (DUBs) that cut and/or edit UB chains on substrates. While numerous neurological
disorders are associated with mutations in the UB enzyme machinery, the role of protein ubiquitination under
non-diseased states and the intricate mechanisms by which proteins become ubiquitinated and deubiquitinated
in the nervous system remain vastly uncharacterized. Using an unbiased proteomics screen for substrates of
the E3 UB ligase RNF216, we identified the DUB OTUD4 and proteins within the OTUD4 interaction network as
substrates. Remarkably, mutations in OTUD4 and RNF216 have been identified in Gordon Holmes syndrome
(GHS), where patients have neuroendocrine dysfunction, neurodegeneration, and dementia. Increases in
OTUD4 mRNA and protein were also identified in individuals with frontotemporal lobar degeneration. Our
preliminary data show that RNF216 regulates OTUD4 ubiquitination, which is reduced in the OTUD4 GHS-
associated mutation. Moreover, OTUD4 was found to de-ubiquitinate RNF216, which was increased in the GHS-
associated mutation. In the proposed work, we will test the hypothesis that excessive OTUD4 DUB activity is a
driving factor in neurodegenerative disease. In Aim 1, we will determine if RNF216 ubiquitination of OTUD4 is
destabilizing and if the OTUD4 GHS mutation has enhanced stability. In Aim 2, we will determine if the interaction
between OTUD4 and RNF216 would enable OTUD4 to function as a direct DUB of RNF216 and affect its stability
and catalytic activity for conjugating UB to substrate proteins. In Aim 3, we will determine if OTUD4 gain-of-
function increases neuroinflammation and leads to reproductive impairments, and if reductions in its activity can
restore these deficiencies in GHS models. Completion of these aims will increase our understanding on how E3s
and DUBs are coordinated in the nervous system. Our work will also outline a mechanism to explain how
mutations and increased activity of OTUD4 drive GHS pathologies, and will identify new therapeutic targets for
the treatment of GHS and other related disorders.

Public health relevance
Project Narrative Neurological diseases are associated with mutations in enzymes that add and remove a tag called ubiquitin to proteins in the cell. This project focuses on determining how the breakdown of interconnected activities of certain genes (the ubiquitin ligase RNF216 and the deubiquitinase OTUD4) lead to disruptions in neural functions associated with the human neurological disorder Gordon Holmes syndrome (GHS). Completion of this work will expand our understanding on how enzymes that add and remove ubiquitin tags work together to regulate neural functions and will further facilitate therapeutic targets for neurological conditions associated with ubiquitin disruption.